Eliminating the latent reservoir by targeted in vivo delivery of HIV-specific CARs

Project Summary
For HIV cure approaches to be widely implemented, they will need to be safe, affordable and
highly effective. The development strategies that allow therapeutic agents to be infused into
people living with HIV (PLWH) rather than being manufactured ex vivo may represent an
important step to reaching this goal. In this application, the investigators merged their expertise
in mRNA lipid nanoparticles (mRNA-LNPs) and HIV CAR technology to propose to develop
injectable agents that will target and remove the latent reservoir. A key advantage of this
approach is that we can target tissues and cells such as the reproductive track or T follicular
cells where CTLs are either excluded or have diminished activity. In Aim 1, we will optimize the
composition of these mRNA-LNPs performing in vitro studies. Once lead compounds are
identified, we will test these in humanized mouse for in vivo activity. Finally, using a state of the
art non-human primate model we will test the ability of mRNA-LNP complexes to reduce the
viral reservoir.

Public health relevance
Project Narrative mRNA-LNPs are the backbone of the highly successful COVID-19 vaccines. We propose to develop mRNA-LNPs that will deliver HIV-specific CARs to tissues and cells that are enriched for cells harboring the latent reservoir. Our underlying hypothesis is that by expressing HIV CARs in areas where HIV hides from CTLs, “kick and kill” strategies will be much more effective in reducing the reservoir.